Native Alzheimer Disease Resource Center for Minority Aging Research (NAD-RCMAR)

OVERALL ABSTRACT
American Indians/Alaska Natives (AI/ANs) and Native Hawaiians and Pacific Islanders (NHPIs) are increasingly
concerned about Alzheimer’s disease and related dementias (ADRD), as these conditions will soon have a major
impact on their communities. Although AI/ANs and NHPIs are culturally diverse, they share a high prevalence of
ADRD risk factors. Life expectancies for AI/ANs and NHPIs have improved resulting in a tripling of their
population share of people aged 65 and older. These changing demographics make ADRD much more visible
in AI/AN and NHPI communities. AI/ANs and NHPIs also face challenges related to their physical, mental,
spiritual, and emotional health over the life course that increases their disparities in health outcomes, reduces
their resiliency in mid- and late-life, and increases their vulnerability and risk of ADRD. The confluence of
perceived need, high risk, and limited data serves as the basis for the renewal application of the Native
Alzheimer’s Disease Resource Center in Minority Aging Research (NAD-RCMAR). Our transdisciplinary
research team offers unique scientific resources and integrates perspectives from multiple disciplines and an
extensive network of community partnerships. Based at the University of Miami along with Washington State
University, Northern Arizona University, University of New Mexico, Wake Forest University, and a network of
Satellite Centers led by Indigenous researchers covering 7 Health and Human Services regions and Hawaii, we
will continue to create and grow an innovative program to understand, intervene on, and mitigate the ADRD-
related health disparities experienced by AI/ANs and NHPIs. Our overarching goals are to fund meritorious Pilot
Studies led by early-stage investigators known as NAD-RCMAR Scientists, whose work will advance our
understanding of ADRD health disparities in AI/AN and NHPI communities; provide NAD-RCMAR Scientists with
mentorship in study design, culturally appropriate research methodology, biostatistical approaches so that their
work meets the highest scientific standards; deliver career development activities to enhance NAD-RCMAR
Scientists' academic advancement and the pursuit of independent careers in ADRD research; and contribute
empirical evidence regarding ADRD in other minority populations. Our Specific Aims are to 1) Build a dynamic
infrastructure, and provide scientific expertise and resources to enhance the diversity of the ADRD research
workforce; 2) Recruit and mentor promising NAD-RCMAR Scientists, especially those of AI/AN, NHPI, and other
URM backgrounds, to conduct Pilot Studies in the social, behavioral, epidemiological, and clinical sciences on
ADRD; and 3) Promote advances in ADRD research and increase the number of independent AI/AN, NHPI and
other URM researchers who can address the health and well-being of AI/AN and NHPI elders. The leadership,
resources, and experience of our team offer an unprecedented opportunity to address NIA’s research priorities
for ADRD among URMs with themes articulated in the 2019 NIA BSR Report. Our Center directly responds to
NIA’s interest in diversifying the scientific workforce.

Public health relevance
OVERALL NARRATIVE We will renew, continue and expand our effort to describe, understand, intervene on, and mitigate the Alzheimer’s disease health disparities experienced by American Indians, Alaska Natives, Native Hawaiians, and Pacific Islanders by studying mid- and late-life resilience and risk factors. We will achieve this goal by funding social and behavioral Pilot Studies that advance the field, emphasizing the recruitment and mentorship of Native junior and mid-level researchers. These trainees will receive training on methods and analyses so that their work meets high scientific standards, while being culturally appropriate. This work will advance Alzheimer’s disease research and increase the number of independent investigators focused on Alzheimer’s disease disparities experienced by our target populations.